Computational Biomechanics Modeling of Inflammation

Project Summary/Abstract
The physical laws that govern the universe also govern the healthy functioning of living tissues, as well as the
genesis and development of diseases. Historically, the biomedical research community has overlooked the role
of mechanics in many developmental, pathological, and adaptive processes. In my research group, the Compu-
tational Mechanics of Morphology at Notre Dame (CoMMaND Lab), we work at the intersection of mechanics,
computation, and biology, to investigate the coupled bio-mechanical behaviors of tissues and organs, particularly
during growth and remodeling. In this proposal, we aim to extend our work to the study of inﬂammatory swelling.
Similarly to growth, inﬂammation and swelling involve local changes in mass (for instance, due to an inﬂux of
cells) which can manifest as changes in volume. While external swelling is often used as an indicator of under-
lying inﬂammation, constraints from surrounding tissue can also restrict swelling and instead result in increases
in pressure. In addition, inﬂammation can drastically change the cellular composition of a tissue. Inﬂammation is
widespread among different tissues, and these sequelae can have important implications for the diagnosis, de-
velopment, and treatment of different diseases. We will developing novel computational models of inﬂammation
and swelling that 1) allow for cell behavior to vary spatially, temporally, and by cell type; 2) account for mechanical
interactions between the swelling tissue and surrounding tissues; and 3) report results in a way that facilitates
calibration, validation, and comparisons with experimental. This work will provide tools for probing small-scale
phenomena beyond large-scale swelling, exploring the effects of individual parameters, and testing hypotheses
regarding the biomechanics of inﬂammation in silico.
1

Public health relevance
Project Narrative The proposed research is relevant to public health because the novel computational models developed will be able to leverage experimental data to help answer fundamental biological questions about the causes and effects of inﬂammatory swelling. Computational models are essential for understanding the complexity of biological systems, and offer safe and effective methods for the testing of hypotheses. Therefore, the project is relevant to the NIGM's mission of increasing our understanding of biological processes and laying the foundation for advances in disease, diagnosis, treatment, and prevention. 1